Fabrication and Testing of a Novel PET insert for Simultaneous PET/MRI

Project Summary. PET (positron emission tomography) is the most sensitive imaging modality available
that can be used both for small animals and humans. We propose to build with our industrial and academic
partners a new generation of PET scanners based on a single crystal tube (ScintoTube – ST‐PET). This will
effectively remove edges from current generation PET scanners. There are distortions at the edges of
scanner elements that effectively reduce spatial resolution and sensitivity. The propose scanner has been
designed and will be built to be used in a magnetic resonance imaging (MRI) scanner. This is an
Academic/Industrial partnership grant. The University of Virginia (UVa) will lead the project. Their partners
include i3M (CSIC ‐ Spanish National Research Council) and Bruker Española. The UVa team has expertise
in testing/validating novel PET scanners, MRI software (pulse programming) and hardware design, and
mouse PET and MRI scanning. I3M and their colleagues at Bruker have a wealth of expertise in designing
and building multimodal scanners, including the Albira trimodal PET/SPECT/CT mouse scanner. Much of
the technology needed for the ST‐PET scanner has been developed by i3M/Bruker and will be ported as
part of this project to the ST‐PET. The proposed work includes: (1) Fabricate a ST‐PET insert for a high field
MRI scanner. The insert will be implemented by i3M and Bruker. Test and validate the ST‐PET scanner
outside the magnet first at i3M and then at UVa. (2) Integrate and test the ST‐PET insert with the 7T
ClinScan MRI at UVa. (3) As a proof‐of‐principle project, use the newly developed ST‐PET/MRI to image
lung cancer progression and metastasis in a mouse model.

Public health relevance
Project Narrative We will build and test a novel PET (positron emission tomography) scanner to be used simultaneously with an MRI. This is based on a recent invention of ours to build the PET scanner using a crystal scintillator tube instead of multiple flat panel detectors. The scanner will be built collaboratively between UVa, i3M, and Bruker.